Howard University Research Center for Minority Health and Health Disparities

Program Director/Principal Investigator (Last, First, Middle):
Alzheimer's disease (AD) is the seventh leading cause of death in the United States during 2019-2020, and the most
common cause of adult-onset dementia, with an increased prevalence and severity in African Americans (AA)
compared to Caucasians, ranging from 14% to almost 100% higher. AD’s risk is increased by other aging-
associated comorbidities including obesity and diabetes. AA have 60% higher risk of type 2 diabetes (T2DM), a
condition that contributes directly to vascular disease that, in turn, may be a particularly powerful factor in the
development of Alzheimer’s in AA. Significant interactions between among serum cholesterol, APOE genotype, and
AD risk were found among elderly AA in prior research, and numerous studies have shown that people with T2DM
have twice the incidence of sporadic AD. Insulin deficiency or insulin resistance facilitates cerebral β-
amyloidogenesis in AD, accompanied by a significant elevation in APP (amyloid precursor protein). Through our
ongoing translational pilot research in an AA population in the DC region, we previously identified gene expression
differences as potential signatures of future AD development in persons with T2DM. Findings suggest that the
amyloid beta in Amyloid Processing Pathways (APP) and Cholesterol (lipid) Biosynthesis Pathways (CBP) may
contribute to the pathogenesis of AD, but we have not fully characterized all the genes in those pathways. We
hypothesize that the APP and CBP pathways (gene expression alterations) in AA T2DM patients are early
identifiers (biomarkers) of future progression to AD. Our interdisciplinary team of clinicians, basic scientists,
epidemiologists, and biostatisticians will bring a high level of scientific rigor to the proposed supplemental project.
Identifying molecular genetic features associated with AD at a preclinical stage is a future research goal that will
contribute to increased accuracy in predicting and managing AD. The specific aims are as follows. Specific Aim 1
is to analyze expression patterns of specific signature genes in the APP & CBP pathways in AA participants
in four groups (persons with T2DM only, with AD only, with both conditions, and with neither condition). To
achieve this goal, we will use pre-configured ALZ-Profiler Arrays (qRT-PCR based profiling) in our stored
biospecimens, coupled with Ingenuity Pathway Analysis (IPA). This seeks to validate the correlations revealed in
our pilot studies, and to better characterize relative expression of key genes throughout these pathways. Specific
Aim 2 is to validate the differentially expressed signature genes identified in Aim #1 across our patient pool.
To achieve this goal, we will use the TaqMan Array to analyze stored bio-specimens from an already recruited patient
pool at Howard University Hospital and validate the precise panel of genes within the particular biological pathways
by integrating the clinical, epidemiologic and laboratory data towards stability, validity, and reproducibility of the
results. This research is a prelude to developing an investigator-initiated RO1 application in the future to shed light
on the possible mechanisms underlying the potential disease burden of AD in AA T2DM patients.
.
Page

Public health relevance
Project Narrative The rationale behind the study is that people of color, especially African Americans, have a higher incidence of Alzheimer’s disease (AD), increased symptom severity, and mortality due to several comorbidity factors, namely obesity and type 2 diabetes, which negatively impact their health. The overreaching goal of this research is to shed new light on possible interactions between AD and diabetes to understand how race may modify the risk and expression of AD; it may yield new insights biological mechanisms that in turn can inform future diagnostic and therapeutic advances.